Activation of Inflammatory Responses Upon Replication Stress in Basal-Like Breast Cancer

Project Summary
Breast cancer accounts for the second most cancer-related deaths in U.S. women despite the
availability of improved treatment options and increased screening. A particularly aggressive
subtype that represents a disproportionate number of these mortality cases is basal-like breast
cancer (BLBC). The high mortality of BLBC stems from a lack of effective, sustainable
chemotherapeutic treatment options with tumors often developing resistance to treatment despite
encouraging treatment responses. This higher relapse rate among BLBC patients calls for the
development of more effective therapeutic regimens targeting distinct molecular alterations of
basal-like tumors. Strikingly, we find that BLBC, but not luminal breast cancer cell lines, exhibit a
severe sensitivity to partial suppression of leading strand replicative polymerase, DNA
polymerase epsilon (POLE). POLE suppression in BLBC cells leads to replication fork stalling,
DNA damage, and a senescence-like state or cell death. Our preliminary data, which form the
premise of my application, reveals that suppression of POLE in a BLBC cell line, but not other
breast cancer cell lines, results in an increase in inflammatory cytokine transcripts known to be
targeted by the NF-𝜅B transcription factor, a phenotype that is dependent upon RELA expression.
This cytokine production is sufficient to impact the tumor immune microenvironment, as I
observed significant infiltration of F4/80 positive macrophages in BLBC xenografts upon POLE
suppression. Therefore, my central hypothesis is that NF-𝜅B activation upon POLE inhibition
activates a cytokine secretion program selectively in BLBC cells. In aim 1, I will analyze activation
of pattern recognition receptors (PRRs) and NF-𝜅B via immunoblot, immunofluorescence for NF-
𝜅B subcellular localization, and an NF-𝜅B luciferase reporter. I will delineate which PRRs (cGAS-
STING, MAVS-RIG-I) and NF-𝜅B components (IKK-g, p65, RELB) are triggered by replication
stress, and use CRISPR/Cas9 to generate cell lines lacking key signaling components to uncover
those responsible for NF-𝜅B activation. In aim 2, I will determine the impact of POLE suppression
on intra-tumoral cytokine expression and tumor cell composition. If immune infiltration is altered,
I will determine the degree of cooperation with immune checkpoint inhibitors. This work is
impactful because it will discriminate whether replication stress induced by inhibiting leading
strand replication triggers an immunostimulatory or immunosuppressive environment that could
be targeted to enhance future anti-cancer therapies.

Public health relevance
Project Narrative As a result of limited treatment options, poor prognosis and the propensity to metastasize, basal-like breast cancer accounts for a disproportionate number of breast cancer-related deaths in U.S. women. Data from our lab shows that suppression of POLE differentially affects inflammatory gene expression of breast cancer cells of the basal type (BLBC) compared to luminal breast cancer cells, raising the question of what underlies these differences and how to leverage them therapeutically. This proposed work may illuminate a strategy for clinically targeting NF-κ B and other pathways sensing genotoxic stress by the innate immune system in tumors primed to activate this pathway.